THE OBJECTIVE OF THIS TASK ORDER IS TO PERFORM DEVELOPMENTAL STUDIES OF ISOTOPE-SPECIFIC 2-KETOGLUTARIC ACID.

Analytical studies are performed to fulfill the regulatory requirement of FDA for the submission of an IND for an imaging agent. The subject task will seek information on the physicochemical characteristics of the new chemical compound and develop validated HPLC assays for purity evaluation.